Robust person-centered longitudinal data analysis for clinical alcohol research

DESCRIPTION (provided by applicant): This application proposes to develop three key components in person-centered longitudinal statistical models: (a) a comprehensive simulation study designed to understand the nuanced performance of a wide range of models used to derive group based trajectories, (b) a cross-validation procedure designed to bolster the confidence (in terms of replication and consistency) of these models when employed in controlled, clinical trials and effectiveness trials, and (c) to promote dissemination of these advanced techniques by developing a user- friendly, freely available software with a graphical-user interface.

Public health relevance
PUBLIC HEALTH RELEVANCE: This application, through comprehensive simulation and benchmarking, develops a foundation for assessing the quality of person-centered longitudinal statistical methods. These methodological developments will provide an advancement in terms of "real world" data analysis by extending the potential models for identifying relevant mediators, moderators, and predictors in controlled, clinical trials and effectiveness trials.